Epigenetic regulation of pulmonary smooth muscle cell remodeling in Pulmonary Hypertension

Progressive and terminal, pulmonary hypertension (PH) is defined by obliteration of proximal pulmonary
vessels, loss of distal microvasculature, and right sided heart failure. Despite pathologic vessel wall thickening
and remodeling being a significant cause of PH morbidity, current therapy targets symptomatic relief of
vasoconstriction and heart failure. While recent studies suggest that aberrant endothelial and smooth muscle
cell gene transcription contributes to PH vascular remodeling, epigenetic regulators that mediate this process
are poorly understood. In other disease processes, the sphingosine kinase (SPHK) 2 / sphingosine 1-
phosphate (S1P) axis is a powerful epigenetic regulator. However, in PH the epigenetic role of SPHK2 has
been largely overlooked. A functionally distinct sphingosine kinase isoenzyme, SPHK2 catalyzes
phosphorylation of nuclear sphingosine, generating S1P, that unleashes transcription co-repressor complexes
to activate latent gene transcription. Our preliminary findings in human PH lung tissues identified a significant
20-fold increase in SPHK2 protein and an altered acetylome via acetylation of histone H3K9 (Ac-H3K9) that is
an active chromatin mark. Moreover, in human pulmonary artery smooth muscle cells (hPASMC) SPHK2
regulated hyperacetylation of H3K9 and promoted transcription of genes known to regulate stemness and
proliferation. Our long-term goal is to develop inhibitors for uncontrolled obliteration of distal pulmonary vessels
that can be used for the clinical treatment of PH. Our overall objectives for this application, which are the next
steps toward attainment of our long-term goal, are to (i) elucidate the epigenetic molecular mechanism(s) and
factors activating SPHK2 that contribute to PH vascular remodeling in vitro and (ii) determine the in vivo
efficacy of pharmacologic SPHK2 inhibitors. Our central hypothesis is that activated SPHK2 promotes distal
pulmonary vascular remodeling through epigenetic modifications that contribute to PH vascular obliteration.
This hypothesis has been formulated based on preliminary data generated using human PH tissue and
hPASMC in vitro, and in vivo hypoxia PH rodent models. At the completion of the proposed research, our
expected outcomes are to have defined the mechanisms by which SPHK2 regulates PH pulmonary vascular
remodeling. These results are expected to have an important positive impact because they will provide a
strong evidence-based proof of principle for development of SPHK2 inhibitors, ultimately providing new
opportunities for development of novel PH therapies.
.

Public health relevance
Narrative: The proposed project is relevant to public health because Pulmonary Hypertension, characterized by high blood pressure in the lungs giving rise to heart failure, is a disease processes that is progressive and debilitating disease with few therapies. The goal of this project is to identify the regulators of the vascular remodeling that contributes to this disease process. Through these studies we believe that new therapeutic targets and clues for future research will emerge that will guide our ability to improve the outcome of patients diagnosed with pulmonary hypertension.